Model-Based Syllabic Prediction in the Avian Auditory Pallium

PROJECT SUMMARY / ABSTRACT
Sensory inputs are often incomplete or degraded by noise. To compensate, the brain uses internal models to
predict what the inputs should be from context, experience, and innate biases. When phonemes are deleted
and replaced with noise, listeners still report hearing continuous speech behind the occluding noise – an
illusory phenomenon known as auditory induction, or restoration (AR). The restored phoneme is biased by the
phonological and lexical context, and by the listener’s native language, pointing to internal representations of
invariant speech patterns that are shaped through experience driving the illusory activity in place of missing
auditory input. Cognitive models of speech perception suggest that restoration likely involves top-down
attention and active feedback from higher-order brain areas onto lower-level auditory areas. Local neural
dynamics within auditory areas, however, may be sufficient for filling in missing information based on temporal
statistical regularities, encoded by means of experience-dependent Hebbian plasticity. The neural mechanism
behind the encoding and activation of internal models of speech remains poorly understood, even amongst the
nonhuman animals that exhibit the auditory illusion. This proposal aims to investigate how the neural dynamics
during the AR illusion are dependent on the statistical regularities of auditory experience, using the zebra finch
and their acoustically rich, but stereotyped songs. The proposal’s central hypothesis is that an experience-
dependent internal model of conspecific song in the zebra finch auditory pallium supports the restoration of
occluded song syllables. Analysis of in vivo extracellular recordings, using unsupervised manifold inference,
will determine the population-level dynamics during the illusion, in the context of both naturalistic and synthetic,
syntactically altered song motifs. Operant behavioral paradigms and acoustical rearing manipulation will be
used to investigate how conspecific syntactic context and auditory experience affect the strength of the
restoration effect. Identifying the neural mechanism behind internal model-based auditory restoration will offer
insight into the broader questions of general perception, memory, and development.

Public health relevance
PROJECT NARRATIVE To understand speech in a complex social environment, the brain learns and detects invariant patterns of speech. In the auditory induction illusion, such internal expectations about the stimulus supersede the actual input to induce the perception of speech phonemes that are not present. Identifying how internal representations of language are formed and employed during the illusion will therefore lead to a more detailed understanding of auditory perception and memory.